Metabolic signals driving cell growth and proliferation

DESCRIPTION (provided by applicant): How cell growth and proliferation are coordinated with metabolism and the metabolic state of a cell remains poorly understood. Previous studies have established that cells must attain a sufficiently favorable metabolic state in order to initiate a program of growth and division. Knowledge of these mechanisms that connect cellular metabolism to cell growth control will provide novel strategies for the treatment of complex metabolic diseases such as cancer. This research proposal aims to understand the mechanisms by which key metabolic and nutritional signals ultimately control cell growth and proliferation. A unique model system wherein a highly synchronized yeast cell population undergoes robust oscillations in oxygen consumption during continuous growth will be used to investigate such mechanisms of growth control. During these metabolic cycles, cell division is precisely gated to a temporal window when the rate of cellular oxygen consumption decreases substantially, which is highly reminiscent of cancer cell division. Cell division initiates only following completion of a burst of mitochondrial respiration that is accompanied by a transient upregulation of growth genes. Just prior to entry into this growth phase, the cell population exists in a metabolic phase that resembles quiescence or G0. Interestingly, addition of select metabolites can trigger exit from this quiescent phase and induce immediate entry into the growth phase. These metabolites are key activators of growth control pathways. This yeast metabolic cycle system will be utilized to understand how cell growth and proliferation are precisely coordinated with metabolic signals and cellular metabolic state. This outstanding problem will be addressed by investigating the mechanisms by which carbon sources signal commitment to growth. In parallel, this system will be used to understand how the conserved TOR growth control pathway becomes active during the switch to growth.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have established a model system that will enable the study of the metabolic and nutritional signals that ultimately control cell growth and proliferation. We hope these studies will provide novel insights into the mechanisms of cell growth control and contribute towards our understanding of complex metabolic diseases such as cancer. Project Narrative: We have established a model system that will enable the study of the metabolic and nutritional signals that ultimately control cell growth and proliferation. We hope these studies will provide novel insights into the mechanisms of cell growth control and contribute towards our understanding of complex metabolic diseases such as cancer. __SpecificAimsTextDelimiter__ Metabolic Signals Driving Cell Growth and Proliferation SPECIFIC AIMS How cell growth and proliferation are coordinated with metabolism and the metabolic state of a cell remains an important open question. When starved for carbon sources or nutrients such as sulfate or phosphate, budding yeast cells engage dedicated strategies to halt metabolism and cell division to promote survivability1, 2. These considerations indicate that cells must attain a sufficiently favorable metabolic state in order to properly initiate growth and division. We have established a system that will enable the study of the metabolic signals that ultimately control cell growth and proliferation. Our previous efforts have focused on the characterization of robust oscillations in oxygen consumption exhibited by budding yeast during continuous growth under glucose-poor conditions, which we have termed yeast metabolic cycles (YMC)3. In short, the YMC depicts the life of a yeast cell population under a glucose-poor growth environment4, 5. We found that a variety of fundamental cellular and metabolic processes are temporally orchestrated about these cycles of oxygen consumption3. Upon analysis of intracellular metabolite abundances, we discovered that profound changes in metabolism and thus cellular metabolic state occur throughout the life cycle of a yeast cell6. Most significantly, we observed that cell division is precisely gated to a temporal window where the rate of cellular oxygen consumption decreases substantially, which is highly reminiscent of the Warburg Effect and cancer cell division3, 7-9. Cell division initiates following completion of a period of intense mitochondrial respiration when many genes involved in growth are transiently upregulated. Just prior to entry into this growth phase, cells exist in a metabolic phase that resembles quiescence or G010. Our preliminary data have shown that addition of particular metabolites can trigger exit from this quiescent-like phase and induce premature entry into the growth phase. Numerous observations suggest these metabolites are key activators of growth control pathways. While products of glycolytic metabolism can induce the switch to growth, we have deduced that acetyl-CoA levels are especially important and function as a key signal of metabolic state. Furthermore, of all the amino acids, leucine is the most potent inducer of growth, and we have accumulated evidence that leucine functions by directly activating the TOR (Target of Rapamycin) pathway. We propose to use this YMC system to understand how cell growth and division are precisely coordinated with metabolic signals and cellular metabolic state. We will approach this problem by investigating the mechanisms by which acetyl-CoA production signals commitment to growth. Our preliminary data have demonstrated that there are a number of important proteins involved in growth that become acetylated only when acetyl-CoA levels within the cell increase. These data indicate that acetyl-CoA functions as a "rheostat" that controls the acetylation of key proteins that are essential for commitment to growth. In parallel, we will exploit the synchronous progression through quiescent and growth phases during the YMC to gain mechanistic insight into the temporal sequence of events leading to the activation of the TOR signaling pathway. Aim 1: Determine the functional role of the acetyl-CoA synthetase enzyme Acs1p. Acetyl-CoA is an important intermediate in central metabolism that has numerous critical functions in cells. However, surprisingly little is known regarding the determinants of acetyl-CoA levels within the cell. Because we have determined that acetyl-CoA functions as an important signal of metabolic state, we propose to elucidate the physiological role of this important enzyme that is involved in regulating acetyl-CoA flux using a combination of genetic and biochemical approaches. Aim 2: Identification and characterization of proteins that are specificaly acetylated upon entry into growth, when acetyl-CoA levels are most abundant. We hypothesize that acetyl-CoA may function as a signal to commit to growth through acetylation of key proteins involved in growth and growth control. Using a combination of genetic and proteomic approaches, we propose to identify and characterize those proteins that are specifically acetylated upon exit from quiescence and entry into growth, with emphasis on understanding how acetylation modulates the function of these key proteins involved in regulating growth. Aim 3: Determine how the TOR pathway becomes activated during the switch to growth. We will use the highly synchronized cell population of the YMC to determine the temporal sequence of events leading to activation of the TOR pathway as cells exit the quiescent metabolic state and enter growth. In parallel, we will use a combination of genetic and biochemical approaches to investigate TOR signaling and how amino acids (in particular leucine) are sensed by the TOR pathway.